Dysregulation of iron homeostasis by mutant LRRK2 in human neurons

Project Summary
The accumulation of iron in the substantia nigra pars compacta (SNc) of Parkinson’s disease (PD) patients has
been confirmed via imaging, histopathological, and biochemical methods. While iron deposition in the SNc
correlates with severity of motor symptoms in patients, whether it is an early precipitating event in disease or a
consequence of human PD pathology is unknown. Multiple missense mutations in LRRK2 cause autosomal
dominant PD and recent data link wild-type LRRK2 signaling to the far more common sporadic PD. The
physiological and pathological functions of LRRK2 have not been fully elucidated. PD-linked mutations can be
found in the kinase domain (G2019S, I2020T) and the ROC/COR bidomain that harbors its GTPase function
(R144C/G/H, Y1699C). These mutations can differ substantially in terms of protein-protein interactions and
kinase activity, yet each are associated with PD. Recent findings from our group indicate that G2019S results
in iron dyshomeostasis, both in vitro and in vivo. Thus far, however, we have only considered this one mutation
and have relied on heterologous overexpression systems or intracranial LPS injection in homozygous knockin
mice to evoke these changes. Whether iron dyshomeostasis is a conserved feature of LRRK2 mutations
beyond G2019S has not been addressed. Furthermore, it is not known whether endogenous heterozygous
LRRK2 mutation is sufficient to drive basal increases in iron. Lastly, in PD patient brain iron deposition is
observed within the substantia nigra and the impact of various LRRK2 mutations in DA neurons is entirely
unknown. Therefore, in Aim 1 we will differentiate a panel of WT, kinase-domain, and non kinase-domain
LRRK2-mutant iPSCs into cortical and DA neurons. Using selective imaging probes and high content imaging,
we will assess cytoplasmic and mitochondrial iron load in human WT and LRRK2 mutant neurons. Total
cellular iron will be quantified by ICP-MS and the role of LRRK2 kinase activity in these effects will be
examined by selective pharmacological inhibition. Secondly, we will explore downstream effects of cellular iron
by assaying expression of iron-related factors and ROS. These experiments will rigorously and unambiguously
determine whether diverse, heterozygous PD mutations in LRRK2 drive iron dyshomeostasis and whether this
effect differs between human cortical and DA neurons. All pathogenic mutations in LRRK2 converge on the
increased phosphorylation of over a dozen Rab GTPases, including Rab8a and Rab10. The contribution of this
phosphorylation to PD etiology remains unknown. LRRK2-dependent phosphorylation is thought to trap Rabs
in a GDP-bound state effectively inhibiting their function. Recent published and preliminary data from our group
link Rab8a to iron metabolism. Therefore, in Aim 2 we will determine whether Rab8a expression is uniquely
sufficient to rescue iron changes in LRRK2 mutant cortical and DA neurons. If successful, this exploratory R21
will codify a novel LRRK2-dependent phenotype in human neurons and provide compelling data to support a
future R01 to explore the pathologic consequences of LRRK2-driven iron dyshomeostasis in neurons and glia.

Public health relevance
Project Narrative One of the common and unexplained features of Parkinson’s disease (PD) pathology is accumulation of iron in brain regions that are affected by the disease. Our published and preliminary data support a role of the PD gene LRRK2 in iron dyshomeostasis in neurons. We set out to interrogate the role of LRRK2 in affecting the way neurons handle iron, and thus leading to iron accumulation and neurodegeneration.